Promoting metabolic maturity of islet organoids pre- and post-transplantation

Type I diabetes (T1D) affects an estimated 1.25 million Americans, and although insulin therapy has been
successful, hypoglycemic events and vascular complications persist. Intraportal allogeneic islet transplantation
has recently become an approved therapy yet is limited in part by a shortage of donor islets. These limitations
have led to the investigation of culturing human pluripotent stem cells (hPSC) to islet organoids as an unlimited
source of functional β-cells. Multiple investigators, including our team, have demonstrated the feasibility of
generating islet organoids in vitro, and transplantation allows a reduction of exogenous insulin. Nevertheless,
analysis of the islet organoids from our laboratory and that of all others indicates that the current culture
platforms do not produce β-cells with mitochondria comparable to that of native pancreatic islets. Mitochondrial
reactions within the metabolic networks of pancreatic ꞵ-cells are responsible for regulating insulin secretion
through KATP channel stimulation, downstream membrane depolarization and insulin granule release. These
reactions make ꞵ-cells obligate mitochondrial respirators, meaning they cannot perform their basic functions by
anaerobic respiration, and highlight the importance of metabolic networks. The metabolic immaturity can lead
to dysfunction and limit survival following transplantation. Herein, we propose to investigate approaches to
enhance metabolic maturity of islet organoids during in vitro culture and post-transplantation into a clinically
translatable site, the omentum. Aim 1 will investigate metabolic and functional maturation of in vitro
differentiated islet organoids using pharmacologic agents and 3D culture to enhance metabolic development
and will develop a dynamic genome wide metabolic model to analyze the impact of these interventions and to
predict additional targets to close the gap between islet organoids and islets. Preliminary data with Exendin-4,
which has been used extensively with islets yet not with organoids, and PPAR agonists that address lipid
metabolism demonstrates an enhanced metabolic pathways and organoid function. 3D culture will be
performed on microporous scaffolds to improve cell interactions and metabolic development in our studies and
other engineered tissues. Aim 2 will investigate metabolic function of organoids post transplantation and will
target the delivery of factor to enhance metabolic maturity and to reduce the impact of factors, such as the
inflammatory mediators TNFα and IFNγ, that contribute to the dysregulation, de-differentiation, or induction of
-cell death. Transplantation will be performed using microporous scaffolds, which have been employed for
islet transplantation to support host integration and restores normoglycemia. As with the first aim, we will
analyze the metabolic function both experimentally and computationally to identify the mechanisms for the
interventions and identify additional targets. We anticipate that directly enhancing metabolic function either
prior to or post-transplantation, or limiting metabolic decline, will limit stress on transplanted cells, and will
enhance survival and function of the islet organoids.

Public health relevance
Type 1 diabetes (T1D) is an autoimmune disease associated with the destruction of insulin producing -cells in the pancreas. Therapies are emerging based on the differentiation of pluripotent stem cells into -cells, and the current procedures for manufacturing result in -cells that are metabolically immature compared to islets. We propose to investigate manufacturing of -cells to enhance their metabolic maturity, and to investigate their transplantation with interventions aimed at supporting metabolic function post-transplantation.